New Reference Signal Injection Method for In Vivo Quantification

DESCRIPTION (provided by applicant): Magnetic resonance spectroscopy (MRS) has evolved from a strictly in vitro research tool for chemists to a powerful, non-invasive, diagnostic technique. However, the full potential of MRS-its ability to quantitatively assess metabolite content in vivo-is rarely achieved in practice. Assessment of metabolite content, commonly referred to as absolute quantification, requires accurate determination of the proportionality factor between the local magnetic field (B1m) generated by excited nuclei within the measurement volume and the integrated area of the corresponding spectral peak in the processed data. An impractical level of diligence is required to quantify or control all of the parameters that affect this proportionality factor. As a result, nearly all MRS results are presented in terms of arbitrary units or as ratios, which are difficult to interpret and of limited clinical value. We have developed a new technique, SPIRIT (Synthetic Peak Injection using a Radiation Immune Tickler coil), that could allow more practical and accurate quantification of MRS. We use a small, inductively coupled RF coil to inject an artificial signal, the pseudo-signal, in the main RF coil used to acquire the in vivo signal. The amplitude, frequency and line-width of the pseudo-signal are easily varied and are first set in proportion to a real peak corresponding to a known in vitro metabolite concentration. The same pseudo-signal is then injected during the data acquisition period of an in vivo measurement and used as a calibration factor to convert the real signals into units of metabolite concentration. The salient feature of the SPIRIT method is the use of inductive coupling to inject the pseudo-signal. Since inductive coupling is also the mechanism by which B1m couples to the main RF coil, any subsequent manipulations of the data that affect the proportionality factor- including coil loading conditions, gain of the receiver amplifiers, and data processing algorithms-have an equal effect on the real and pseudo-signals. This makes the proportionality factor immune to these data manipulations and substantially decreases the burden of the metabolite quantification process. We have built a prototype SPIRIT probe that uses a surface coil to excite and receive the in vivo signals. This simple coil was useful for demonstrating feasibility but, like all surface coils, it creates a nonuniform B1 field, which complicates the quantification process. In this project we will build two additional SPIRIT probes that create uniform B1 fields to excite and receive the metabolite signals, validate the method by comparison against biochemical assays of metabolite content in rat hind limb, and demonstrate the ability to accurately quantify changes in metabolite content in human skeletal muscle during physiological perturbations. Our project focuses on measurements in skeletal muscle but the methods could easily be transferred to other organs. Our goal is to validate a powerful new tool for noninvasive quantification of metabolite content that will allow researchers and clinicians access to the full potential of MRS. PUBLIC HEALTH RELEVANCE: We have developed a new method of converting magnetic resonance spectroscopy (MRS) data into units of metabolite concentration. We propose to validate the method in animal studies and demonstrate its value in humans. Successful completion of the project could have widespread impact on a variety of diseases by providing researchers and clinicians with a more practical noninvasive tool for measuring metabolite concentration.

Public health relevance
Project Narrative We have developed a new method of converting magnetic resonance spectroscopy (MRS) data into units of metabolite concentration. We propose to validate the method in animal studies and demonstrate its value in humans. Successful completion of the project could have widespread impact on a variety of diseases by providing researchers and clinicians with a more practical noninvasive tool for measuring metabolite concentration.